Sustained Triumvirate Delivery by Contact Lens for Post-Surgical Management

Cataract surgery has become a very common procedure with about 10 million cataract operations each year in the world1
with a significant increase expected due to aging of the population. The surgery could result in significant inflammation
which is managed by instillation of eye drops to deliver antibiotics, steroids and NSAID but this approach has many
problems including low bioavailability3 and <50% compliance.4 In fact, in almost 93% cases, patents use incorrect
technique to administer the eyedrops5. These deficiencies have driven research in developing devices for sustained release
of dexamethasone such as DEXYCUTM and DEXTENZA®. While these offer benefits, neither deliver all drugs and so
patients may still require instillation of antibiotic eye drops to minimize the possibility of infections. We will solve this
problem by designing contact lenses that can deliver all three drugs at controlled rates for extended durations with high
bioavailability making this significantly superior to the drop-based therapy as well as other commercial devices. In addition
to post cataract, our approach will be usable for any post-surgical management including Photo refractive keratectomy
(PRK) which already involves placing a bandage lens after surgery. Contacts lenses offer many advantages over eye drops
including sustained release that will improve compliance by replacing about 100 drops with 1-4 lenses and higher
bioavailability that will lead to more consistent concentrations in ocular tissues resulting in improved therapy. We have
developed a novel, patented approach for extended delivery by incorporation of vitamin E (a tocopherol) in commercial
silicone hydrogel contact lenses. Use of commercial contact lenses that are already approved by the FDA, reduces barriers
to translation. Our approach is also innovative because of the ease with which the barriers can be incorporated via simple
soaking steps first in a solution of vitamin E and ethanol, followed by in DI water. Our considerable prior results have
shown that our approach increases the drug release duration of multiple ophthalmic drugs which is critical to this project
while maintaining all key properties of the contact lenses including transparency, wettability, UV-blocking, and oxygen
permeability. Specifically, we showed that incorporation of 30% (w/w) on dry basis of vitamin E in ACUVUE OASYS
lenses increases the release duration of levofloxacin to 3 days and dexamethasone and ketorolac to >7 days. This research
aims to manufacture and characterize the lenses in Aim 1 and test pharmacokinetics in New Zealand white rabbits in Aim
2. The approach will provide insights into sustained drug delivery and efficacy with NB-CL, and lead to a novel device for
post-surgical management in a sustained manner. Our approach promises to improve compliance and minimize drug
variations to improve therapy. After completion of Phase 1 studies proposed here, we will submit an IND enabling Phase
2 proposal focusing on proving efficacy in a surgical model of New Zealand White rabbit model.

Public health relevance
Post-surgical management after ophthalmic surgeries requires multiple eye drops of anti-inflammatory and antibiotics at different frequencies and low bioavailability of 1-5%. We propose to develop drug eluting contact lenses capable of delivering about 50% dose to target tissues allowing replacement of tedious drop therapy involving tens of drops of three different drugs with use of a contact lens for 7-days followed by another lens, if needed. The proposed research aims to manufacture and characterize the lenses and measure in vivo drug release in New Zealand White rabbit model.